Neuroimaging Dimensions at the Extremes of the Schizophrenia Spectrum

PROJECT SUMMARY
Schizophrenia (SZ) is a severe mental health disorder currently treated with antipsychotic drugs which often
have serious side effects, are ineffective in ~30% of patients, and are not useful as a preventive treatment. With
its burden estimated at $343.2 billion in the US alone, there is a pressing need to improve early identification
strategies for SZ and treatments that improve functioning. A better understanding of the underlying neurobiology
is key to achieving these goals. Advances in global, large-scale, collaborative neuroimaging efforts are able to
generate replicable findings on brain abnormalities in SZ and assess contributions of clinical and confounding
variables. Our prior work within the ENIGMA (Enhancing Neuroimaging Genetics through Meta-Analysis) SZ
working group identified predominantly gray matter deficiencies such as smaller subcortical volumes and thinner
cortex in SZ. However, our findings also highlighted the importance of confounding variables on such clinical
neuroimaging data, such as antipsychotic medication or disease chronicity. In contrast, the ENIGMA Schizotypy
(SZT) working group, studying well-functioning healthy individuals who self-report subclinical psychotic traits,
recently found that higher SZT was associated with thicker cortex. Moreover, the cortical thickness profile in SZT
was inversely related with the profile of cortical thinning in SZ. Based on these findings, we posit that a
comprehensive characterization of neural abnormalities at the extremes of the SZ spectrum continuum may not
only further our understanding of the low liability (SZT) and high liability (SZ) ends of the spectrum but may also
have wider implications for the prediction of risk and resilience in SZ (functioning) and in individuals at clinical
high-risk for psychosis. This innovative global initiative will be first to integrate data across ENIGMA SZT and SZ
cohorts with structural MRI (sMRI), detailed diffusion tensor imaging (DTI), and resting-state functional MRI
(rsfMRI) to address the following key questions in SZ research: what are the functional and structural connectivity
signatures of SZT and SZ? How are these signatures related to symptom severity, and global functioning? Can
label-noise reduced dimensional measures of SZT and SZ liability based on these multimodal neuroimaging
measures predict poor functioning? Leveraging global data and expert teams from minimally 24 to possibly well
over 100 cohorts, we will tackle imaging, clinical, and predictive questions about the SZ spectrum with
unprecedented power. This project will employ standardized image analyses, quality assurance, and statistical
analysis procedures across cohorts with multimodal neuroimaging and clinical data from the same individuals.
This will yield replicated FC and SC signatures of SZT and SZ, determine relationships between neuroimaging
markers of SZT and SZ, and relationships with symptom dimensions and functioning. It will deliver machine-
learning based models that can be used to generate imaging-based, dimensional, biomarkers that may serve as
treatment targets, predictors of clinical outcome, or predictors of conversion to psychosis in at-risk populations.

Public health relevance
PROJECT NARRATIVE The proposed study will deliver replicated findings of functional and structural connectivity abnormalities in schizotypy and schizophrenia based on large-scale, global, collaborative meta-analyses. It will identify shared brain connectivity abnormalities, associated with overlapping symptoms, and unique brain connectivity abnormalities, associated with non-overlapping functioning profiles between schizotypy and schizophrenia which lie at the extremes of the schizophrenia spectrum continuum. Finally, the study will generate label-noise-reduced, machine-learning based models that generate schizotypy protective and schizophrenia liability scores that may serve as biomarkers for functioning, and that may be predictive of functional outcome in schizophrenia and possibly individuals at clinical high risk for psychosis.